Cancer Biology Training Program

Project Summary
We request a further five years of funding for our T32 to support broad-based, interdepartmental pre- and
postdoctoral training in cancer biology at the University of Texas Health Science Center at San Antonio
(UTHSA), a designated Hispanic-Serving Institution. In this next funding period (years 11-15), we request 3
predoctoral slots and 3 postdoctoral slots. Our Cancer Biology Training Program is the only NCI-funded T32 at
UTHSA. We provide intensive and rigorous training in cancer research and discovery under the tutelage of
seasoned preceptors and professional development opportunities to highly motivated graduate students and
postdoctoral research fellows, especially those from groups underrepresented (UR) in biomedical research.
Since this T32 was first awarded in August 2011, all trainee positions (1 predoctoral and 3 postdoctoral in each
award year) have been filled, and trainees have been highly productive. To date, 7 predoctoral students and 15
postdoctoral fellows have been appointed as T32 trainees, and 41% (2 predocs and 7 postdocs) are URs. The
Training Program will continue to be directed by the same Director and Co-Director, enhanced by a new Co-
Director, and overseen by a seasoned Executive Committee. The training faculty is diverse, with 19 full
professors and 5 associate professors, and 7 assistant professors as Co-Mentors, from 9 departments. All
training faculty have full faculty privileges in the Graduate School and our NCI-designated Mays Cancer Center
(MCC). Our training faculty are highly interactive with numerous collaborative publications, have strong funded
research portfolios (average direct costs >$870K per mentor in the current year), and are experienced and
successful in mentoring predoctoral and postdoctoral trainees. Many new Training Program-specific activities
leverage growing basic, translational and clinical cancer research opportunities (especially at the MCC) in
bioinformatics, drug development, and cutting-edge shared resources. Annual Retreats and bi-monthly
Trainees’ Luncheons will allow trainees to showcase their research advances and interact with the Program
Co-Directors, the training faculty, the External Advisory Board, and other trainees, including those who have
completed training. The curriculum also includes training in scientific communication and a strong base in
responsible conduct of research as well as rigor and reproducibility. Trainees will be selected for their
academic accomplishments and their dedication to cancer research and will be appointed for 2 years. There is
substantial institutional commitment to this Training Program, e.g. salary support for the Program Director, and
matching support from the MCC for a fourth predoctoral trainee. Our Cancer Biology Training Program seeks
this continuation to continue its contribution to diversity in the next generation of independent investigators
working to accomplish NCI’s goal of improving cancer prevention, detection, diagnosis, treatment, and
survivorship.

Public health relevance
Project Narrative A steady stream of new researchers is necessary to continue the fight against cancer, the primary cause of death in the U.S. The training of a diverse workforce is a key component to the next generation of scientists. The goal of this Cancer Biology Training Program is to continue to give trainees a broad exposure to the many areas of cancer research, so that they can learn multidisciplinary and cutting-edge approaches to better understand and treat cancer, thereby reducing its overall burden nationwide.